Targeting Non-Canonical STING Signaling to Treat SPOP Mutant Castration-Resistant Prostate Cancer

PROJECT SUMMARY/ABSTRACT
Tumor suppressor gene speckle-type POZ protein (SPOP), a substrate adaptor of cullin3-RING ubiquitin ligase,
demonstrates heterozygous missense mutations in up to 15% of prostate cancers, yet the functional significance
of these SPOP mutations is largely unknown. We identified SPOP-binding consensus motifs in multiple proteins
of the canonical cGAS-STING and non-canonical STING-NF-κB pathways and demonstrated that human and
mouse STING protein is a bona fide SPOP target. Analysis of SPOP mutant (SPOPmut) and SPOP wild-type
(SPOPwt) castration-resistant prostate cancer (CRPC) clinical data sets revealed a 29-gene “SPOPmut gene
signature”, which reflected STING-NF-κB signaling activity and suggested a role for the recruitment of tumor
microenvironment (TME)–facilitated tumor cell growth and survival in SPOPmut CRPC. Further evaluation of the
“SPOPmut gene signature” in primary, untreated prostate cancer from TCGA revealed a subset of SPOP mutant
tumors, as well as a subset of CHD1 mutant (CHD1mut) tumors, that are enriched for the signature. Importantly,
co-mutations in SPOP and CHD1 (chromatin remodeling factor) are well documented. In stably transduced
human and mouse SPOPmut (SPOPF102C and SPOPF133V)–expressing CRPC models, we demonstrated
upregulation of non-canonical STING-NF-κB-IL-6 pathway proteins, STAT3, and HMG proteins involved in
promoting secretory pathway activities. We also showed that PARP inhibitor (PARPi) treatment of SPOPmut
CRPC cells induces DNA damage, activates canonical cGAS-STING-TBK-IFN-ß signaling and suppresses non-
canonical STING-NF-κB-IL-6/STAT3, in part through inhibitory phosphorylation (S754-STAT3), leading to growth
suppression and apoptotic signaling. Olaparib (OLA) increased IFN-β secretion and reduced viability to a greater
extent in SPOPmut prostate cancer cells than in control cells in coculture with macrophages versus monoculture.
In addition, activation of cGAS-STING and induction of IFN-ß in macrophages were demonstrated only in OLA-
treated coculture models, and neutralizing antibody experiments showed that paracrine regulation of OLA-
mediated growth suppression involved IFN-β induction and IL-6 suppression of SPOPmut prostate cancer cells.
We hypothesize that SPOPmut, CHD1 deletion (CHD1del) and SPOP + CHD1 co-mutations in prostate cancers
promote PARPi or PARPi + anti-IL-6 therapeutic efficacy through enhanced synthetic lethality driven by
increased, unrepaired DNA damage, which leads to a shift in the balance toward canonical cGAS-STING-IFN-ß
signaling and suppression of IL-6/STAT3. We propose to analyze the underlying mechanisms of the SPOPmut
and CHD1del prostate cancer phenotype and define these genetically driven TME alterations and their protein
effectors through macrophage reprogramming using state-of-the-art proteomics (Aim 1); analyze the efficacy of
PARPi and anti-IL-6 treatment in SPOPmut (F133V), CHD1del, and SPOPmut;CHD1del RM-1-BM syngeneic
CRPC models (Aim 2); and analyze clinical trial tissue and blood samples from PARPi-treated SPOPmut and
CHD1mut prostate cancer patients for biomarkers of this genetically driven phenotype (Aim 3).

Public health relevance
PROJECT NARRATIVE Analysis of SPOP mutant (SPOPmut) and SPOP wild-type castration-resistant prostate cancer (CRPC) clinical data sets revealed a 29-gene “SPOPmut gene signature,” which experimentally reflected intrinsic epithelial non- canonical STING-NF-κB and paracrine-mediated macrophage signaling activities driving tumor cell growth and survival in SPOPmut CRPC. We also showed that PARP inhibitor (PARPi) treatment of SPOPmut CRPC cells markedly induces DNA damage, activates canonical cGAS-STING-TBK-IFN-ß signaling, and suppresses non- canonical STING-NF-κB-IL-6/STAT3, in part through inhibitory phosphorylation (S754-STAT3), leading to growth suppression and apoptotic signaling. Our proposed, paradigm-shifting studies will define the underlying mechanisms and clinical markers in prostate cancer models and tissue samples from PARPi-based clinical trials to understand how PARPi influences innate and adaptive immune signaling in the context of SPOPmut prostate cancer and potentially other genetic mutations (e.g., CHD1 deletions) that reflect the SPOPmut phenotype.